Medical Scientist Training Program

This application requests support for the Medical Scientist Training Program (MSTP) at Stony Brook University.
Continuously supported by the NIGMS since 1992, our MD-PhD program has a 41-year history of training
physician-scientists, many of whom have gone on to make important discoveries and become leaders in
biomedical research at academic medical centers across the country. Of our 149 graduates thus far, 30% are
still in training in strong academic medical programs. Of those beyond training, 52% have academic faculty
positions, many of which are highly prestigious, or are affiliated with university hospitals, 21% have primarily
clinical university hospital positions but contribute as educators and have academic connections, 13% have
taken on roles in biotechnology / pharmaceutical groups or heath-care leadership, and 13% are in private
practice. The goal of the program is to provide a rigorous training path that creates and fosters a physician-
scientist mentality and a culture that imbues trainees with the tools, motivation, identity, and drive to pursue
careers in academic medicine. Students are exposed to both clinical and basic scientific activities throughout
their training, reinforcing the special nature of this program. Core courses unique to our MSTP include monthly
seminar / dinners with both internal and external physician-scientist speakers, and a monthly journal club –
clinical pathological correlation dinner-evening that combines basic science with clinical applications in an active-
learning manner. Our students also receive training in our unique Alan Alda Center for Communicating Science
(AACCS); partnership of the AACCS with the MSTP to develop new courses including ones on professional skills
resulted in a first-place award from the AAMC. PhD degrees are offered in a wide range of disciplines with the
students being guided to undertake high-quality basic / translational science training at SBU, Cold Spring Harbor
Laboratory, or Brookhaven National Laboratory to address problems relevant to human health. Being on the
same campus with the rest of our large university, we have particularly strong computational, AI, and
Bioinformatics training programs and resources. The MSTP has grown from 58 students 10 years ago to 77 now,
51% of whom contribute to diversity of our physician-scientist training pool. The annual institutional support to
the MSTP has correspondingly increased, the applicant pool size has increased, and both applicant and
matriculant quality remain strong. We typically matriculate 8 students per year and add on average another
student from the incoming medical school class. Many of our students hold individual NRSAs, publish high-
impact articles, and have received a variety of honors, both intra- and extramurally. Overall time-to-graduation
has averaged 7.8 years over the past decade. On average, MSTPs receive support for 25% of the funding years;
in this application, we request that level of support, 18 lines, to appoint trainees for the MS1-2 years, i.e. for 1/4th
of the length of the expected period of training in the Program. We are committed to the training of exceptional
physician-scientists, which NIH funding will greatly facilitate.

Public health relevance
Narrative The Stony Brook School of Medicine is committed to the training of future physician-scientists to address a pressing need for individuals who can undertake scientific discovery with direct relevance to human health. Trainees undertake a rigorous academic program that culminates in the awarding of an MD and a PhD and many go on to become leaders in biomedical research.